Saving and Retirement

DESCRIPTION (provided by applicant): This project analyzes the interrelationships between saving and employment behavior at older ages. The adequacy of saving for retirement is an issue with important implications for government policy. Many households do not accumulate enough wealth to maintain their pre-retirement level of consumption following retirement. This is often asserted to be inconsistent with the implications of forward-looking life cycle models. However, most studies in the retirement-savings literature take the timing of retirement as given, and analyze saving or consumption behavior conditional on retirement. Just as there is wide dispersion in wealth at retirement, there is also wide dispersion in the age of retirement. If patience and preferences for leisure are correlated, and if consumers exercise choice over both retirement and saving, then conditioning on the age of retirement in the analysis of saving behavior could produce misleading inferences. This project will estimate a structural dynamic model of saving and employment behavior in which these decisions are made jointly. There are no published studies that take a structural approach to this problem, yet the payoff of this approach to increasing understanding of the forces leading to the observed extreme heterogeneity of saving for retirement is likely to be quite high.